Regulation of cytosolic pattern recognition receptor signaling in macrophages

DESCRIPTION (provided by applicant): Invading pathogens are recognized by pattern recognition receptors (PRRs) of the innate immune system as a first line of defense. Activation of PRRs from the Nucleotide-binding and leucine-rich repeat containing (NLR) protein family and Absent in melanoma 2 (AIM2) in macrophages results in inflammasome formation. Inflammasomes are protein platforms that are essential for the activation of inflammatory Caspases and subsequently for the maturation and release of the pro-inflammatory cytokines interleukin (IL)-1β and IL-18. Assembly of inflammasomes depends on PYRIN domain (PYD)-mediated recruitment of the adaptor protein ASC to activated PRRs, which then recruits pro-Caspase-1. In addition, Caspase-4, -5 and -8 participate. However, the molecular mechanism of inflammasome activation by cytosolic PRRs and in particular, regulation and termination of this process is poorly understood. We discovered a family of small proteins composed of only a PYD, called PYD-containing (PYDC or POP) proteins. We show that PYDCs function to inhibit inflammasome activation by blocking the PYD-PYD interactions essential for inflammasome formation. However, their precise role and contribution to in vivo host defense and inflammatory disease is still unknown. Inflammasomes are essential for host defense; however, inappropriate inflammasome activation also causes excessive and chronic inflammation, tissue destruction and the debilitating symptoms of the growing autoinflammatory diseases. Therefore, a balanced inflammasome response to allow pathogen clearance during acute infection, while preventing systemic inflammation through timely termination, is essential for homeostasis. We hypothesize that it is the role of the PYDC proteins to maintain this balanced inflammasome response through a negative feedback mechanism. Since PYDC proteins are lacking from mice, we generated novel mouse models to simulate the more complex inflammasome regulation evolved in humans. We propose to determine PYDC-mediated inflammasome regulation and termination during all known scenarios of inflammasome activation: pathogen infection/pathogen-associated molecular pattern (PAMP), tissue damage/damage associated molecular pattern (DAMP) and hereditary PRR mutation in macrophages and in vivo. We will focus on select inflammasome-activating PRRs. In aim 1 we will determine the molecular mechanism of inflammasome regulation and termination for each PYDC ex vivo in macrophages and in aim 2 we propose to determine PYDC-mediated inflammasome regulation in vivo. Collectively, our study is designed to establish the specific inflammasome regulatory function of the PYDC family during infection and inflammatory disease, which we expect will significantly advance our understanding of fundamental biological principles underlying innate immunity, host defense and inflammatory disease and the mechanism by which these responses are regulated.

Public health relevance
PUBLIC HEALTH RELEVANCE: Cytosolic pattern recognition receptors (PRRs) sense pathogen and danger patterns and initiate host defense through regulation of cytokine production by inflammasomes, however, uncontrolled PRR activity and failure to timely terminate signals, thus excessive production of IL-1� and IL-18, is directly responsible for the debilitating symptoms of an increasing number of inflammatory diseases, while their limited activity impairs host defense. We identified all three members and established the PYRIN domain-containing (PYDC) protein family, which are centrally positioned to regulate key cytosolic PRRs and to terminate inflammasome activation, and propose to elucidate their function in human macrophages and in mouse models in vivo, to firmly establish their role as regulators of cytosolic PRRs. This study is expected to positively affect human health by providing the basis for the development of novel and improved treatment strategies to block activity of cytosolic PRRs in inflammatory disease and to enhance it to combat infections. At the same time, the fundamentally new information obtained about cytosolic PRR regulation is expected to significantly advance our understanding of innate immunity and host defense.